The mechanism of nucleophagy in rejuvenating the nuclear envelope

PROJECT SUMMARY
Over the last 10 years, the lysosome-mediated degradation pathway macroautophagy has gained prominence
in the study of aging-related disorders and extension of lifespan. Macroautophagy is an essential cellular
pathway responsible for the elimination of cytosolic proteins, lipids, and organelles, and as such, the field has
focused upon the role of macroautophagy in clearing protein aggregates or dysfunctional organelles (such as
mitochondria) that specifically accumulate in the cytoplasm. Increasingly however, protein and toxic lipid
accumulation and organelle dysfunction are observed to occur within the nucleus, apparently shielded from
cytoplasmic processes by the double-membraned nuclear envelope. Furthermore, links between aging and
nuclear envelope structural defects are emerging, including nuclear envelopathies caused by mutations in the
envelope scaffolding lamins and associated integral inner nuclear membrane proteins. Recent work has also
established that the nuclear envelope is a hotspot for lipid metabolism, raising the specter that the buildup of
toxic lipid species may impact nuclear envelope function if they are not effectively cleared. There is compelling
evidence that components of the nuclear envelope and the nucleus are subject to macroautophagy-dependent
turnover (termed nucleophagy) but the molecular mechanisms remain unknown. Here, we leverage the S.
cerevisiae model to define the molecular and ultrastructural steps that define a model nucleophagy pathway. In
our published and preliminary data, we establish a kinetic and ultrastructural timeline of nucleophagy. We will
use these data to integrate molecular machineries that we have already discovered into this timeline to
understand the mechanisms that underpin each step. These experiments will be supported by in vitro
reconstitution to provide a deep insight into how these factors remodel the nuclear membranes. Lastly, we test
the innovative hypothesis that nucleophagy clears toxic lipid species in order to rejuvenate the nuclear
membranes and ensure robust chronological lifespan. The latter will employ leading-edge lipidomics platforms
to provide much needed insight into how the nuclear envelope lipidome is altered during aging.

Public health relevance
Project Narrative Aging related disorders are strongly associated with a reduced capacity to induce the autophagy stress response and increasingly are also associated with the accumulation of structural defects along the nuclear membranes. Neither the physiologic overlaps between these two phenotypes, nor the mechanistic underpinnings of autophagy-dependent nuclear envelope remodeling are well characterized. To identify how autophagy can help limit age-related nuclear envelope dysfunction, our proposal focuses on describing the molecular requirements and mechanistic events that drive nuclear autophagy.